Evolution of new protein function in the multi-protein, multi-functional Toll-like receptor 4 complex

Project summary
We propose purchasing a High-Performance Liquid Chromatography (HPLC) system to place
in-line with an existing multi-angle laser light scattering instrument in the Harms lab. This will
allow us to precisely characterize the oligomeric states of TLR4 (Toll-like receptor 4) and its
associated proteins. The overall goal of the funded parent project is to dissect the evolution of
the TLR4 protein complexes over the last 400 million years. TLR4 is an important driver for
inflammation in both healthy contexts (e.g, response to infection, wound healing) and
pathological cancers (e.g., chronic inflammation, cancer). It interacts with multiple protein
partners as part of these functions, including MD-2, CD14, and S100A9. To understand the
evolution and mechanism by which the TLR4 complex has its effects, we need sharp tools to
dissect the interactions between these proteins.
All three aims of the parent project will benefit from the requested instrumentation. The first
two aims require understanding how TLR4 binds to different agonist molecules and
oligomerizes in response; the third aim looks the evolution of the key support molecule CD14,
which directly binds TLR4. The ability to directly measure protein-protein interactions and
oligomerization is critical to achieving these aims.

Public health relevance
Project Narrative The goal of the parent grant is to dissect the evolution of the multi-protein, multi-functional protein complexes formed by Toll-like receptor 4 (TLR4). TLR4 is an important driver for inflammation in both healthy and pathological contexts. It evolved the ability to form complexes with a wide variety of protein partners. The equipment supplement will be used to acquire instrumentation that will allow us to directly study the assembly of these complexes and thus better understand their biochemistry and function.